Biogenesis of voltage-gated K+ channels

Our research program aims to understand how a voltage-gated potassium (Kv) channel is made. This is a
complicated multi-step process that requires acquisition of local secondary, tertiary, and quaternary structures,
either sequentially or as coupled events. How this happens is, for the most part, unknown. Yet the impact of
these steps is profound, often with pathological consequences. We focus our attention on the human tetrameric
Kv1.3 channel, particularly its early-stage folding, and the determinants that regulate these folding events in
the exit tunnel of the ribosome and the ER membrane. Three Aims comprise this grant proposal. The ability of
a protein to form helices is a fundamental prerequisite for protein folding and function in all proteomes.
However, this process has not been defined in the confined and heterogeneous microenvironment of the
ribosome exit tunnel where a protein is first made. Helicity must occur at the right time and place during
translation. Failure to meet this requirement impairs peptide targeting, chaperone association, efficient bilayer
insertion, and oligomerization. In Aim 1, we specifically ask when, where, how, and why these critical
secondary structures arise in the Kv1.3 nascent peptide. We will determine the molecular mechanisms that
delay or initiate helix formation and identify the underlying peptide-tunnel interactions that are responsible.
To do this, we use biochemical approaches and cryo-EM single particle reconstruction of peptide-ribosome
complexes. In Aim 2, we explore an exciting new field of fundamental importance to how proteins are made,
namely, how a peptide's sequence generates piconewtons of force that fine tune Kv peptide's rate of elongation
and folding efficiency. We use experimental approaches and molecular dynamics simulations to identify the
type of peptide-tunnel interactions giving rise to force, the nature of the force, and its consequences as the
peptide is elongated. Given that human Kv1.3 is expressed in neuronal and immune cells, and impaired
expression produces chronic inflammatory disease and autoimmune disorders, it is compelling to ask whether
human disease-linked variants of the KCNA3, the gene that encodes Kv1.3, introduce
folding/assembly/trafficking defects. In Aim 3, we address this question using the recently developed “genome-
first” approach to determine the clinical consequences of specific KCNA3 rare variants and biophysical
determinations of Kv1.3 folding and function to identify the molecular defects. Our overall vision of Kv folding
includes complex coupled events between intrapeptide segments, the ribosome exit tunnel, and the ER
membrane. We now expand this view by introducing two new concepts for further investigation: 1)
repressor/activator activity acts as a molecular switch to govern the time and tunnel location of Kv helix
initiation, and 2) cotranslational force generation modulates translation rates and folding. Both concepts
represent paradigm shifts that reveal additional levels of regulation for Kv channel folding and may generalize
to the biogenesis of other proteins.

Public health relevance
PROJECT NARRATIVE Our research aims to understand how proteins, specifically potassium channels, are made and fold to function correctly. Defects in these processes lead to pathology and even death. Our discoveries will identify the problems when proteins do not fold properly and will enable therapeutic drugs to be designed to combat these fundamental causes of disease.